Northwestern Cancer Prevention Consortium

Northwestern University proposes to continue to lead a consortium of organizations, the Northwestern Cancer
Prevention Consortium (NCPC), to design and conduct early phase clinical trials aimed at developing new
options for the prevention of cancer. To date, NCPC trials, 19 in total, have accrued 534 patients (354 from the
2003 consortium and 175 from the 2012 consortium), targeting multiple organ sites and a variety of agents. We
have tested innovative concepts, e.g., transdermal drug delivery, and utilized novel biomarkers, such as
nanocytological alterations. Our proposal to renew the NCPC, under the leadership of Seema A. Khan MD
includes academic partners included in the current consortium and new members who are expected to add
important strengths to it (the University of Toronto and City of Hope). In the new cycle of the NCPC, we will
continue to build on promising approaches based on prior or ongoing successful trials, while providing
oversight, consultation, and administrative support to cancer prevention research teams. We will assist in the
design of cancer prevention trials, in proposal and protocol development, and in the implementation of such
trials. Our overarching goal is to continue our contributions to cancer prevention science
through the development of innovative, transformative, early phase trials testing new conceptual
approaches that will enable clinical advances in the prevention of cancer. Our Aims are to 1.
Advance high priorities in cancer prevention, for maximum impact on cancer incidence when these are
advanced into clinical use. These priorities include (i) investigate novel agents and repurposed agents that
target mutations and pathways known to be important in the development of cancer, (ii) novel or
established biomarkers to identify individuals most like to predict benefit from a given approach, (iii) trials
that will result in unifying biological themes across different organ sites, leading to protection against more
than one cancer type, (iv) test innovative dosing and delivery methods, to reduce the symptom and
toxicity burden for users of cancer prevention agents. 2. Provide consultation, scientific guidance, and
mentoring to consortium investigators who are proposing new trial concepts; assist consortium investigators
through trial design, initiation, conduct, and analysis; and to serve as the administrative hub of the
consortium. We will foster communication, collaboration, and sharing of available resources
between consortium members and across consortia, to maximize impact of clinical trials testing similar
interventions or in similar populations. Serve as a liaison between the consortium and the NCI DCP, by
maintaining and improving an NCPC 3. Advance the science of cancer prevention, through evaluation
and selection of innovative or transformative concepts that result in progress that is greater than the sum
of knowledge gained from the specific goals of an individual trial. We will be guided in this process
by an Advisory Committee with a diverse background in cancer prevention research.

Public health relevance
PROJECT NARRATIVE Although there have been tremendous advances in cancer therapy, cancer remains a feared, disabling, and lethal disease; its prevention through the use of medications that will halt or reverse early lesions has particular promise since the complexity of changes that allow fully developed cancer to evade treatment has not yet occurred. We will conduct clinical trials to test medications that appear promising for the purposes of cancer prevention; these trials will tell us whether a particular medication is worth testing in larger trials, how it works, and who will be most likely to benefit from it. We will, in particular, focus on common cancers (breast, colon); those that are both common and lethal (lung); and those that are lethal and often fail treatment (liver, pancreas).